Interferon-Induced Transmembrane Protein 3 (IFITM3) Regulates Thrombosis During Inflammation in Aging

PROJECT SUMMARY/ABSTRACT
Aging is accompanied by a decreased tolerance to physiological stress, which promotes increased susceptibility
to inflammatory illnesses. Critical illnesses such as sepsis, disportionately effect people over the age of 65,
leading to increased morbidity and mortality in older adults. Thrombosis is a common complication from sepsis,
contributing to organ failure and death. The significance of this devastating dysregulated host response is
demonstrated by data showing half of all hospital intensive care admissions are from individuals over the age of
65 and may be attributed to infection. Emerging evidence supports the concept that dysregulated platelet
functions mediate the injurious host response during inflammation. Nevertheless, the molecular mechanisms
and functional consequences of dysregulated platelet functions during aging and inflammation remain
incompletely understood. Our proposal, entitled “Interferon-Induced Transmembrane Protein 3 (IFITM3)
Regulates Thrombosis During Inflammation in Aging” will identify new pathways by which inflammatory agonists,
including interferons (IFNs), regulate gene expression in platelets and their parent cell, the megakaryocyte (MK),
in aging. Our preliminary studies have identified that the expression of IFITM3 is robustly induced in human
platelets during sepsis, a systemic inflammatory illness. Interestingly, MKs and platelets from aged human and
mice express more IFITM3 after IFN stimulation compared to younger controls. Our data suggest that IFITM3
promotes fibrinogen endocytosis in MKs and platelets, leading to platelet hyperreactivity and thrombosis. Our
findings also suggest that in aging and during inflammatory stress, the mammalian target of rapamycin pathway
is activated, triggering IFITM3 synthesis and thrombosis. The expression and function of IFITM3 in MKs and
platelets and its regulation by mTOR is a pathway not previously examined. In this proposal, we will couple
studies in older and younger septic patients with in vitro and in vivo murine models using aged mice. These
complementary human and murine studies will allow us to establish clinical relevance, while also dissecting the
mechanisms by which IFITM3 governs MK and platelet function during inflammation. These studies are
translational and innovative as IFITM3 regulation of endocytosis, a process critical for cellular function,
has not previously been studied in MKs, platelets, or – for that matter - any primary human cells. They
will also determine for the first time whether aging alters the effect of inflammatory agonists on transcriptional
and translational events in MKs and platelets. This work will test an important functional hypothesis and
clarify pathophysiologic mechanisms of thrombosis aging during inflammation. This proposal has
translational potential for older patients with sepsis, and also will uncover new pathways linking
thrombosis and inflammation in aging.

Public health relevance
PROJECT NARRATIVE Megakaryocytes and platelets regulate thrombosis in older adults. Results generated from this work will advance our understanding of how translational control of gene expression in platelets and megakaryocytes regulates thrombosis during aging and inflammation.